Defining a type II IL-9R

PROJECT SUMMARY / ABSTRACT – Defining a type II IL-9R
Cells communicate through specific cytokine-receptor binding to mediate immune responses and
inflammation. Targeting these interactions has become an effective approach to patient treatment in a growing
list of diseases. Among the cytokines, IL-9 is pleiotropic and is involved in allergic and autoimmune diseases
and in tumor immunity. In hematopoietic cells IL-9 signals through the IL-9Rα chain and the γc chain that is
shared with other cytokines including IL-2, IL-4, and IL-7. Numerous reports, including our own, demonstrate the
ability of IL-9 to stimulate direct effects in non-hematopoietic cells as well. Yet, the hematopoietic-restricted
expression of γc leaves a gap in our knowledge of how IL-9 delivers a signal to non-hematopoietic cells. The
related cytokine IL-4 has a type II receptor that is composed of the IL-4Rα chain and the IL-13Rα1 chain to
facilitate responses in non-hematopoietic cells. In this application we provide evidence of a type II IL-9R that is
proposed to function in non-hematopoietic cells. We hypothesize that on airway epithelial cells IL-9Rα can
combine with IL-13Rα1 to form a type II receptor and we provide preliminary data of a physical interaction
between these receptor chains. We will test this hypothesis using gene-targeted mice and both in vitro and in
vivo model systems to analyze IL-9 signaling and IL-9 function in airway epithelial cells. Together, these studies
will expand the paradigm of cytokine receptor biology, provide detailed insight into IL-9 effector functions, and
further define how targeting cytokine receptor chains impacts immunity in the patient population.

Public health relevance
PROJECT NARRATIVE The development of allergic inflammation in the airways depends upon cytokines that are secreted by various cell types in the lung to orchestrate the inflammatory process. This is dependent upon cells that respond to those cytokines. In this proposal we define an alternative receptor for one of those cytokines that is present on non-hematopoietic cells.